Impacts of the Pennsylvania Rural Health Model on Health Care Access and Utilization

PROJECT SUMMARY/ABSTRACT
More than 130 rural hospitals in the U.S. have closed over the past decade, exacerbating challenges that rural
communities face accessing care and contributing to rural health disparities. The Pennsylvania Rural Health
Model (PARHM) is a novel alternative payment model (APM) intended to ensure the financial viability of rural
hospitals, increase access to high-quality hospital services, and improve population health in underserved rural
communities. The two main components of PARHM are global budgets and hospital-specific transformation
plans. Global budgets are prospective payments made by payers to cover all inpatient and hospital-based
outpatient services. Global budgets decouple hospital revenue from volume, as currently exists under fee-for-
service payment, and therefore incentivize the efficient use of medical services and promote reduction of
avoidable hospitalizations. Through transformation plans, hospitals develop plans to tailor services to the
needs of the local community. The goal is to make meaningful improvements in the quality of the care hospitals
provide and address the most pressing health needs in their communities to improve population health and
realize future savings. Hospitals joined PARHM in cohorts over three years. We leverage variation in
implementation of PARHM and a within-state control group of eligible but non-participating hospitals to
evaluate the effects of PARHM using a difference-in-differences design to compare differences in trends. We
propose the following aims: Aim 1. Examine the association of PARHM with rural hospitals’ provision of
traditionally unprofitable service lines and patient use of those services. We hypothesize that treated hospitals
will be more likely to continue offering selected hospital service lines that are of particular significance to rural
areas and have traditionally been considered unprofitable (i.e., obstetrics, psychiatric, substance use disorder).
Furthermore, we hypothesize that utilization rates for these services will increase more in treated vs. control
groups. Aim 2. Assess the impact of PARHM on rates of potentially avoidable hospitalizations (PAHs) for
ambulatory care sensitive conditions. We hypothesize that PAH rates will decrease more in treated vs. control
groups as a result of improved ambulatory care coordination and financial incentives. Overall, this study will
address the current gap in the literature regarding PARHM on health outcomes and global budgets on hospital
service lines. This project will provide novel evidence about how global budgets affect access to hospital
services and health outcomes in rural communities—critical for evaluating PARHM’s performance and
informing future payment models targeted to NIHMD health disparities communities. Completion of this project
and the associated training goals will provide the PI with training to become a physician-scientist with the
training and skills to critically evaluate and inform payment and health care delivery policy for underserved
communities in the United States.

Public health relevance
PROJECT NARRATIVE Through global budgets and hospital-specific transformation plans, the Pennsylvania Rural Health Model (PARHM) has the potential to reduce rural health disparities by improving the financial viability of participating hospitals and incentivizing improvements in population health. The proposed research aims to determine PARHM’s impact on the provision of traditionally unprofitable hospital service lines, the change in utilization rates of those services, and the change in rates of potentially avoidable hospitalization in hospital service areas, applying a health equity lens to frame our analysis. Our results will help determine the success of PARHM and inform the design and implementation of future alternative payment models in rural settings.